Developmental Program

Developmental Program Abstract Our Developmental Program strategy will include both the Pilot Projects and Auxiliary Projects. These programs facilitate seeding new ideas and efforts for which no direct funding mechanism exists since not enough preliminary data has been accumulated or needs an incentive to bring scientists with diverse skill sets to address a difficult question. This has been a highly successful program in previous phases, and has resulted in a large number of publications and further funding opportunities. We will expand the Pilot Program by allocating $100,000 per year of CCNE funds. This allocation will again be matched dollar for dollar through a commitment we negotiated from the CINM and LCCC (Letter of Support in Overall Section 1). This collaboration will result in a total of $200,000 per year to support four $50,000 per year Pilot Projects. In Auxiliary Projects, is designed to foster collaborations between various Nano Alliance members and other institutions to provide additional scientific expertise that benefits both groups. For C- CCNE Phase 3, $50,000 annually has been dedicated for Auxiliary Projects. This ties in extremely well with UNC's goals of supporting research intended to encourage collaboration of investigators from different disciplines, institutions and communities that result in transformative approaches to healthcare issues.